Peer-Led Support Intervention for Black Breast Cancer Survivors

PROJECT SUMMARY
Compared to non-Hispanic White women, Black women with breast cancer have a 41% higher mortality rate
and experience worse psychosocial outcomes, such as greater psychological distress and poorer health-
related quality of life (HRQOL). Current psychosocial support interventions are not culturally sensitive to the
lived experience of Black breast cancer survivors (BBCS), which is shaped by disproportionate and unjust
exposure to social determinants of health (SDOH) and life course stress. BBCS report a greater need for
emotional and informational support from other BBCS; therefore, psychosocial support interventions may be
optimally delivered by peer health workers (peers) who in the context of a formal intervention, provide culturally
sensitive support through the shared lived experience, knowledge, and characteristics of other BBCS. The
purpose of the proposed K23 award is to examine the feasibility, acceptability, and preliminary efficacy of a
peer-led, manualized, web-based support intervention to reduce distress and improve HRQOL among BBCS.
In aim 1, we will recruit and establish a community advisory board (CAB) to collaborate on all phases of the
study, including recruitment; developing and refining the intervention; piloting the randomized controlled trial
(RCT); and analyzing and disseminating the findings. In aim 2, we will co-design and iteratively refine a peer-
led support intervention through focus groups with BBCS (N=20) to identify the preferred content, format, and
delivery of the intervention. We will manualize and further refine the intervention through individual qualitative
interviews with a sub-sample of BBCS (N=10). In aim 3, we will conduct a pilot randomized controlled trial
(RCT) to assess the feasibility, acceptability, and preliminary efficacy (on reducing distress and improving
HRQOL) of the peer-led support intervention (N=30) (culturally sensitive educational support + peer support)
compared to the control arm (N=30). To isolate the effect of the peer, the control arm will include culturally
sensitive educational support delivered by an oncology nurse scientist (no peer support). Peer support will be
guided by their shared lived experience and principles of motivational interviewing. from trained peers will
provide culturally sensitive support to reduce distress and improve HRQOL of BBCS. The K23 will provide the
essential mentoring and training to become an independent investigator focused on providing equitable cancer
survivorship care for BBCS. The proposed mentoring team has the expertise to provide in-depth training to
achieve the following goals: (1) obtain knowledge and experience with clinical trial design and community
engaged (CEnR) methods to support the development and refinement of a peer-led support intervention
focused on reducing distress and improving the HRQOL among BBCS; (2) obtain knowledge and skills in
conducting research that incorporates multi-level social determinants of heath, especially as they pertain to
health disparities and distress among BBCS; and (3) prepare and secure R01-level funding to test the efficacy
of the peer-led support intervention in a larger, fully powered randomized controlled trial.

Public health relevance
PROJECT NARRATIVE Compared to non-Hispanic White women, Black women have a 41% higher mortality rate and experience worse psychosocial outcomes, including greater psychological distress and lower health related quality of life (HRQOL). Aligned with the NINR’s research lenses of health equity and social determinants of health, the proposed study will examine the feasibility, acceptability, and preliminary efficacy of a collaboratively and iteratively designed and refined peer-led support intervention to reduce psychological distress and improve HRQOL among Black breast cancer survivors. Findings will lay the groundwork to test the intervention’s efficacy in a fully powered randomized controlled trial (RCT).